The Development of Novel Disinfectants to Overcome Bacterial Resistance

Project Summary
Bacterial infections cause a tremendous burden to human health, and our first line of defense – amphiphilic
disinfectants and antiseptics – rely on century-old technology and are now susceptible to bacterial resistance.
This research program has worked for over a decade to develop novel disinfectants, broadly expanding
beyond the dogmatic reliance on single-cation amphiphiles like benzalkonium chloride. We aim to capitalize
on recent insights, and forge innovations as yet unseen by bacteria. Specifically, we will continue to explore
phosphorus-based analogues to traditional disinfectants (quaternary phosphonium compounds or QPCs);
work to improve atom economy and mitigate toxicity via innovative structure design; endeavor to better
understand how a cationic center (whatever the element) influences bioactivity; and finally broaden our
understanding of structure-activity relationships, anchored by specific knowledge of charge density and
solution behaviors.
While our group has prepared roughly 840 novel disinfectant compounds to date, of first priority will be the
construction of an even wider variety of amphiphilic structures. This will take advantage of our recent
discoveries in multicationic QPC structure classes, which show the ability to eradicate bacterial strains that
have otherwise been deemed pan-resistant. Compounds with bushy-tails – species bearing multiple mid-
length alkyl chains – as well as chimeric phosphonium/ammonium hybrids and less-explored
bolaamphiphilic structures will be pursued to broaden out structure-activity relationship understanding.
We also aim to better understand how the electronic nature of our cationic atom (P vs N) in our
amphiphiles can correlate to, and ultimately predict, bioactivity. Charge density analyses (aided by x-ray
structure analysis in the lab of Michael Zdilla at Temple University) and Hammett-style electron density-
vs-bioactivity plots will enhance our fundamental understanding of how cationic character influences
antimicrobial activity and resistance susceptibility. Dynamic surface tension behavior data will be correlated
to time-kill observations to further expand the utility of these disinfectants.
At the forefront of this research program is the work of undergraduate collaborators, who have been
the drivers of our 36 publications in this field, and serve as first authors on 10 of our papers. We envision
continuing to employ straightforward chemical syntheses, based on hypothesis-driven rationales. The result is
twofold: we are able to learn a great deal about the antibacterial activity of QPC and QAC scaffolds with
evaluations of individual structural motifs in a very short period of time, and our students are able to
experience interdisciplinary science, as part of a collaborative, multidisciplinary team to advance our
knowledge.

Public health relevance
Project Narrative This collaborative project utilizes synthetic organic chemistry, physical organic chemistry, and microbiological analysis to develop novel disinfectant compounds to combat pathogenic bacteria, and shed light on why bacteria can resist the traditional disinfectants that have been used for nearly a century. Moving beyond traditional structural classes of disinfectants that have become susceptible to bacterial resistance, we will develop fundamentally different structures that, when paired with careful analyses of their physical properties and solution behavior, will shape the next generation of antimicrobials.